Multiscale Insights into the Epigenetic Basis of THC Consumption

Project Summary
The United States is in the midst of a significant paradigm shift around the perception and use of cannabis. The
majority of states now permit recreational or medical use, reflecting a shift in views of cannabis with many
believing the drug is not harmful or addictive. Despite the rise in these beliefs, repeated large-scale reports show
that 10-30% of regular users meet the criteria for cannabis use disorder (CUD), an addictive disorder
characterized by loss of control over use and relapse. As cannabis becomes more broadly available, it is
essential that we determine the foundational mechanisms that drive problematic use. A major obstacle in
studying CUD has been the lack of preclinical models of drug use. To bridge this gap, we have implemented a
translational model of volitional edible ∆-9-tetrahydrocannabinol (THC; the main psychoactive constituent in
cannabis) consumption to assess drug taking and seeking. With this paradigm we observed that unlike
intravenous self-administration models, rats readily consume THC gelatin. Critically, this model recapitulates
drug taking and cognitive phenotypes observed in CUD including increased drug intake and cue-induced seeking
in males as well as individual differences in the capacity to titrate intake. This model provides a powerful
foundation to assess neurobiological mechanisms that drive CUD-like behavior. Such clear sex and individual
differences suggest potential involvement of epigenetic factors contributing to these phenotypes. Drugs of
misuse like cannabis induce changes in epigenetic mechanisms such as histone modifications (e.g. methylation)
which impact the accessibility of chromatin, permitting or suppressing gene expression. These mechanisms can
activate or inhibit molecular machinery underlying synaptic plasticity leading to addiction-like behaviors. Recent
clinical data indicate cannabis use is associated with changes in DNA methylation, and animal models have
demonstrated a causal impact of THC exposure on epigenetic substrates throughout the mesocorticolimbic
system. Using unbiased RNA sequencing of the nucleus accumbens core (NAcC), a reward subregion implicated
in addiction, we observed dysregulation of transcripts underlying synaptic plasticity associated with changes in
histone methylation. Although epigenetic mechanisms are a promising target for mitigating addictive behaviors,
these mechanisms are tightly coordinated in a cell-type specific manner which can influence phenotypes. To
improve the development and translation of novel therapeutics for addictions like CUD that target epigenetic
mechanisms, it is essential we develop a cell-type specific understanding of the recruitment and role of these
mechanisms in problematic cannabis use. This award will be used to interrogate the impact of histone
methylation of distinct NAcC neuron outputs on the transcriptome, calcium activity, and regional
networks. This program will be the first to show the causal impact of epigenetic modifiers on behaviors
that promote and maintain CUD and will provide critical insight into novel therapeutic targets.

Public health relevance
Project narrative With the advent of legalization, cannabis availability and use are at record highs which has raised concerns regarding increased incidence of cannabis use disorder (CUD). The experiments in this proposal will fill gaps in knowledge regarding the epigenetic mechanisms underlying vulnerability to develop CUD. This research will provide significant insights about cell-type specific epigenetic, transcriptomic, physiological, and neural network signatures associated with high THC consumption and expand understanding of the mechanisms underlying cannabis use disorder.